Imitation from television during infancy

DESCRIPTION (provided by applicant): Although infants are exposed to television for many hours per day during infancy, very little is known about its real behavioral impact. To date we know that by 14- to 18-months, infants can imitate simple actions they saw on television 1 day earlier. Their ability to imitate televised actions, however, lags significantly behind their ability to imitate those same actions that were demonstrated by a live model. The basis for this lag is unclear, but several possibilities are obvious. First, laboratory studies have used only very short single presentations, but in the real world, the same televised information is typically frequently repeated within a segment and presented on many occasions. Second, laboratory studies have not included features common to commercially available televised programs. Finally, laboratory studies have presented only an isolated piece of televised information, but in the real world, multiple pieces of information are typically presented at once. In three studies, independent groups of 12-, 15-, 18-, and 21-month-old will be exposed to live or videotaped demonstrations of target actions, and their imitation performance will be measured 24 hr later. In the first study, the number of repetitions of the target actions will be increased from 3 to 6 for the video group and will continue to be doubled until infants in the video group imitate the same number of actions as infants in the live group. In the second study, attention to and imitation of televised sequences containing sound effects and lively music will be measured. In the third study ways to increase generalization and transfer of knowledge gained from television to objects that differ in size or shape will be examined (1) by modeling the target actions on a variety of stimuli and (2) by modeling the target actions on one object after preexposure to two objects that differ in shape and/or color. In both cases, infants will be tested with the original object or one that differs in color and/or shape. The results will have important theoretical implications for infant memory processing of two-dimensionally presented information. They will also have important applied implications for developing effective educational programs for normal infants and intervention programs for compromised infants in this expanding digital world.